APOE and microglia-mediated progression in tau pathology in AD

We have previously reported that microglia and extracellular vesicles (EVs) play pivotal roles in tau
propagation. Our findings have been reproduced in numerous studies showing involvement of microglia and
EVs in the development of tau pathology in animal models and human biospecimens. During the current
funded period (1RF1 AG054199), we identified: 1) Enrichment of glial and disease-associated proteins in
Alzheimer’s disease brain-derived EVs (AD EVs) compared to control EVs, 2) Highly transmissible nature of
AD EVs demonstrated by increased neuronal uptake and tau aggregation potency, 3) Robust tau propagation
throughout the entire hippocampus by inoculating AD EVs containing just 300 pg of tau in aged C57BL/6
mouse brains. We have yet to elucidate the underlying mechanism of AD EVs gaining pathogenic functions.
We hypothesize that Ab-induced inflammatory conditions in AD leads to microglial activation, which alters
molecular compositions of microglial EVs, leading to their increased transmission to neurons. APOE4
enhances this process by augmented Ab deposition and MGnD induction. The hypothesis has been developed
based on the previous studies and our preliminary data showing that (1) Clec7a+ neurodegenerative microglia
(MGnD) surrounding Ab plaques play a key role in accelerating tau propagation in APPNL-G-F/NL-G-F knock-in
(APP KI) mice; (2) MGnD upregulates EV markers; (3) AD EVs and APP mouse brain-derived EVs show
elevated MGnD and cell adhesion molecules compared to controls; (4) AD EVs show increased tau seeding
activity and neuronal uptake compared to controls, which is exacerbated in APOE4 over non-APOE4 AD
cohorts; and (5) APOE4 knock-in APP/PS1 mice accelerates Ab deposition, microglial activation, and
expression of MGnD markers compared to APOE3 knock-in APP/PS1 mice. The rationale of the proposed
research is that identification of EV protein and lipid composition uniquely expressed in AD and APOE4
background will serve as the basis of molecular understanding of EV-mediated disease progression. Our study
will fill the missing link between MGnD induction and tau propagation by microglial tau-seeding EV production.
In Aim 1, we will delineate the chemical and molecular structure of aggregation-prone tau in AD EVs and tau-
interacting molecules. We will also characterize the protein and lipid compositions of EVs from APOE4/4 and
APOE3/3 EVs to characterize the difference in cellular origin, involvement of inflammatory and toxic molecules,
and tau seeding activity in vitro and in vivo. In Aim 2, we will knock down Apoe, involved in microglial activation
and Smpd3, involved in EV synthesis, to determine the role of MGnD induction and glial EV production on tau
propagation. In Aim 3, we will differentiate isogenic human iPSCs in APOE3/3 and APOE4/4 background to
microglia-like cells (iMGL), and characterize pathogenicity of iMGL EVs under MGnD condition. We will
perform proteomic and lipidomic profiling of iMGL EVs to validate our findings from human AD EVs in Aim 1.
The proposed work is expected to obtain the fundamental molecular bases for EV biology in tauopathy.

Public health relevance
The renewal application will test our hypothesis that amyloid-β deposition in human Alzheimer's disease (AD) brain, which activates brain macrophage “microglia,” and enhances seeding of tau aggregates via phagocytosis of tau-containing neuronal processes and secretion of extracellular vesicles. This will be conducted by 1) characterization of the tau seeding activity of extracellular vesicles isolated from AD brains, 2) microglia-specific deletion of microglia activator or glia specific deletion of extracellular vesicle producing enzyme in animal models and 3) characterization of extracellular vesicles isolated from activated pluripotent stem cell-derived microglia-like cells. This study is critically relevant to understand the progression of neurodegenerative diseases and will elucidate potential therapeutic targets.